Using gene expression to identify patients at high risk for late breast cancer recurrence

PROJECT SUMMARY
Non-metastatic breast cancer is treated surgically and with adjuvant therapies. As these treatments have
improved, recurrence-free survival has steadily increased, and late recurrence (recurrence beyond 10 years’
survival) has become a pressing issue for patients and providers. There are existing and emerging therapies
that prophylactically target dormant breast tumors to prevent late recurrence. However, these therapies carry
substantial toxicities and should only be used in women who are at high risk for late recurrence. No prognostic
assay is recognized by the American Society of Clinical Oncology or by the National Comprehensive Cancer
Network to reliably predict recurrence risk beyond 5 to 10 years. Our proposed work differs from earlier studies
of late recurrence biomarkers by including large samples of premenopausal and postmenopausal ER-positive
breast cancer patients who have survived 10 years recurrence-free, and by following patients for up to 20
years after initial diagnosis.
Within strata of menopausal status at diagnosis, we will identify 200 cases of late distant recurrence (occuring
>10 years after initial diagnosis and treatment) and match to these 200 recurrence-free controls on follow-up
time as well as calendar year, menopausal status, age, and stage at diagnosis. We will identify gene
expression profiles specific to late recurrence risk by comparing expression patterns in late recurrences and
controls using a robust ensemble of conventional and machine learning models We will bolster the rigor and
reproducibility of the identified expression panel by (a) fitting a host of viable models to identify predictive gene
expression levels and combining these into a powerful, consolidated ensemble; (b) employing in-sample cross-
validation to minimize the likelihood of overfitting and false-positive findings, and (c) assessing independence
of disovered genes from genes used in existing early recurrence models.
At project completion, we will have developed a primary breast tumor gene expression profile that can stratify
ER-positive breast cancer patients with respect to their late recurrence risk. This approach will provide
accurate risk stratification and a long lead time for initiating prophylactic therapy with one of several existing
and emerging drugs that eradicate or stabilize dormant tumor foci. The genes contributing to our new profile
and their associated biological pathways may also suggest new therapeutic targets to prevent late recurrence.

Public health relevance
PROJECT NARRATIVE There are more than 2 million American women who have survived breast cancer for five or more years, and for whom risk of late recurrence is a never-ending concern. We propose to discover the first molecular test to predict a woman’s risk for late breast cancer recurrence. Such a test would allow risk stratification for initiating one of several new and emerging therapies to prevent late recurrence.